SMILE-PD: Similarity Matching In Longitudinal Electronic Patient Data

PROJECT SUMMARY
The NIH All of Us (AoU) Research Program is a national research initiative launched by the
National Institutes of Health (NIH) in May 2018 with the goal of advancing precision medicine,
which aims to provide personalized medical treatment and prevention strategies based on an
individual's unique genetic, environmental, and lifestyle factors. Analysis of real world data like
AoU typically requires creation of cohorts that are clinically similar with the exception of the
characteristic(s) being evaluated. If the creation of compared cohorts is not conducted with
care, results may be confounded by systematic difference in the characteristics of patients
assigned to the compared cohorts. This proposal, Similarity Matching In Longitudinal Electronic
Patient Data (SMILE PD), will apply a sophisticated patient matching algorithm within an easy-
to-use interface to help Investigators to create suitable analytical cohorts to enable generation of
accurate, reproducible real world evidence from the rich content of the All of Us data.
The project has 4 Aims :
• Aim 1. Develop algorithms that learn patient similarities from AoU data in a
comprehensive manner.
• Aim 2: Develop approaches that can integrate drug and disease information from
publicly available data sources to improve the quality of learned patient similarities.
• Aim 3: Implement an interactive user interface to specify similarity matching criteria
and demonstrate the learned patient similarities
• Aim 4 : Apply the patient similarity matching algorithm and interface to conduct an
initial assessment of the impact of mental illness and its treatment on chronic disease
outcomes
The patient similarity matching interface created through this proposal will enable investigators to
conduct predictive analytics, risk assessments and comparative effectiveness research in a more
robust and reproducible fashion.

Public health relevance
Project Narrative Analysis of real world data for risk assessment or comparative effectiveness research requires creation of cohorts that are clinically similar with the exception of the characteristic(s) being evaluated. Results may be confounded by systematic difference in the characteristics of patients assigned to the compared cohorts. The Similarity Matching In Longitudinal Electronic Patient Data (SMILE PD) project will apply a sophisticated patient matching algorithm within an easy-to-use interface to help Investigators to create suitable analytical cohorts to enable generation of accurate, reproducible real world evidence from the rich content of the All of Us data.